STANDING COMMITTEE ON EVIDENCE SYNTHESIS AND COMMUNICATIONS IN DIET AND CHRONIC DISEASE RELATIONSHIPS

A deeper examination of the issues related to research design and methodological approaches to evidence synthesis on diet-disease relationships and risk of chronic disease is needed to better inform the public about dietary choices to advance health and reduce risk of chronic disease. To respond to this need, a standing committee of approximately 8–10 members will be formed to monitor the current literature and identify emerging issues related to advancing the strength and rigor of scientific evidence in nutrition research on chronic disease risk; including effective communication of scientific evidence to the public. Alzheimer's disease